Regulation of PRC2 by protein and RNA interactions during differentiation

ABSTRACT
During development, a single human genome gives rise to hundreds of differentiated cell types that must
maintain their distinct identities. Proteins and complexes of the Polycomb group modify chromatin chemically
and physically and are required to maintain repression of lineage-specific genes in inappropriate cell types.
The Polycomb repressive complex 2 (PRC2) interprets the transcriptional and epigenetic state of the nucleus
and trimethylates histone H3 at lysine 27 (H3K27me3), which imposes chromatin-based silencing. The self-
propagating nature of H3K27me3 explains the epigenetic maintenance of these silent chromatin domains once
established, and therefore the maintenance of appropriate cell identities; however, different genes are
silenced by PRC2 in different lineages, suggesting that at critical junctures in development, PRC2 must be
able to select new genes to be repressed.
The goal of this proposal is to decipher the molecular logic that controls the establishment of new PRC2-
silenced chromatin domains during development. Specifically, we will test the hypothesis that the two PRC2
complex types, PRC2.1 and PRC2.2 silence different genes during development due to their distinct
accessory protein subunits and interacting RNAs. We will test this hypothesis with two specific aims.
In Aim 1, we will utilize a state-of-the art inducible protein degradation system to discern the roles of PRC2.1
and PRC2.2 at two critical steps of early development, the transition from ground to primed pluripotency and
the commitment to the neural lineage. We will induce degradation of accessory subunits that define the two
complex types and analyze molecular and functional phenotypes at different time points during the directed
differentiation of embryonic stem cells into neuronal progenitors. The reversibility of the protein degradation
system will allow us to restore the complexes during or after differentiation and determine the exact moment at
which their function is required.
In Aim 2, we will follow up on our recently published work that identified multiple RNA-binding protein surfaces
on both PRC2.1 and PRC2.2 and use this information to design separation-of-function RNA-binding
mutants. With these mutants, we will identify RNAs bound to the different subunits of PRC2.1 and PRC2.2.
Next, we will utilize inducible protein degradation followed by rescue with RNA-binding mutants to determine
how RNA interactions contribute to PRC2.1 and PRC2.2 recruitment and function on chromatin.
The proposed studies will provide insight on the molecular mechanisms that underpin the creation of new silent
chromatin regions by PRC2 during differentiation, with broad implications for our understanding of epigenetic
processes during normal development and their dysregulation in disease.

Public health relevance
PROJECT NARRATIVE Proteins of the Polycomb group maintain cell identity during development by preventing the activation of inappropriate parts of the genome. The Polycomb repressive complex 2 (PRC2) selects which genes need to be silenced and mutations in this complex cause developmental disorders and cancer. This proposal investigates how proteins and RNAs that bind to PRC2 contribute to its selectivity for different genes in different tissues, therefore contributing to the maintenance of cell identity during development.